Behavioral Intervention Development Core

OTHER PROJECT INFORMATION – Summary/Abstract
Behavioral Intervention Development Core
The BID core is the scientific focus of the Center. Through statistically-powered clinical trials, the core evaluates
mechanisms of behavior change that can drive health-related actions, and tests interventions that nudge
behaviors in ways that are likely to improve health outcomes. Roughly two clinical trials will be initiated each
year, including continuations and extensions of ongoing Center trials. Among the categories of health-related
behavior we plan to study are interventions to increase healthy behaviors, decrease unhealthy behaviors, and
improve provider decision-making. Our mission is to move promising interventions through the NIH Stage Model,
from basic science (Stage 0) and initial intervention development and testing (Stage 1), through efficacy (Stage
2-3) and effectiveness (Stage 4) testing, and eventually on to dissemination and implementation research (Stage
5). A unique feature of our BID core is infrastructure to partner with researchers at Geisinger Clinic, a non-profit
health care network and insurer with a rich history of innovative delivery reforms and experimental research.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Behavioral Intervention Development Core Health is a foundational source of wellbeing for people of all ages, and readily affected by our lifestyle decisions, behavioral interactions with the health care system, and responses to adverse health events when they inevitably occur. In the BID core, we will use statistically-powered clinical trials to evaluate mechanisms of behavior change and test promising interventions, with the goal of improving population health.